Reducing Susceptibility to Environmental Stress Throughout the Life Span

DESCRIPTION (provided by applicant): The mission of the Career Development Project is: 1) to develop future leaders in the environmental health sciences by developing early career scientists, and 2) to support investigators who will integrate human studies into environmental health science.